Multi-site External Validation and Improvement of a Clinical Screening Tool for Future Firearm Violence

ABSTRACT
Interventions in clinical settings, such as the emergency department (ED), are an opportunity for
interpersonal firearm violence prevention, particularly among youth, whom interpersonal firearm violence
disproportionately affects. A crucial prerequisite to successful clinical interventions is an accurate gauge of risk,
to ensure the judicious allocation of scarce resources; providing that missing prerequisite is the primary goal of
the proposed work. Machine learning methods, in contrast to traditional inferential statistical models, are
distinguished by their emphasis on prospective prediction, and have enhanced clinical prediction in several fields,
including heart disease, cancer diagnosis and outcomes, PTSD, suicide risk, and substance use, among others.
Yet, with the exception of the SAFETY score—developed by the current investigative team—machine learning
methods have not been leveraged to prospectively predict firearm violence. In this proposed work our research
objectives are two-fold: 1) Externally validate the SAFETY score by determining its ability to predict firearm
violence involvement within the next year on a new data set; and 2) Improve the SAFETY score by conducting
a comparative analysis of four powerful machine learning methods: elastic net penalized logistic regression,
random forests, support vector machines, and boosting (ensemble) methods. In this way, we are responding to
Objective One: Research to help inform the development of innovative and promising opportunities to enhance
safety and prevent firearm-related injuries, deaths, and crime. This approach is innovative because it builds upon
the only work to apply machine learning methods to firearm violence prediction, and it is a promising opportunity
to prevent firearm injuries because it will a) provide an explicit gauge of future firearm violence risk; and b)
characterize risk factor effects in terms of their prospective prediction ability, unlike any prior research. Thus this
research will both identify individuals in most need of intervention, and also point to potentially modifiable
predictive factors. Properly addressing this research question in a generalizable way requires a contemporary
data set with 1) a focus on a high-need, yet broad, study population; 2) comprehensive baseline measures that
provide a broad basis for prediction; and 3) geographic variability (Midwest, West Coast, and East Coast) that
enhances generalizability. Thus, we will recruit 1,500 youth age 18-24 from urban EDs in three broadly different
locales—Flint, Philadelphia, and Seattle—and administer a baseline survey covering several domains of
potential risk factors for future violence, and follow up with those youth at 6- and 12-months to ascertain the
primary outcome—firearm violence involvement (as victim or perpetrator)—as well as the secondary outcomes:
high-risk firearm behaviors, non-firearm violence, and violent injury. Because this work requires a prospective
longitudinal study, we are applying for Option B. This work will lay the ground for future research involving the
development and testing of interventions for interpersonal firearm violence both by identifying potential high-
leverage modifiable predictive factors, and by identifying youth most in need of intervention.

Public health relevance
PROJECT NARRATIVE The purpose of the proposed work is to harness cutting-edge machine learning methods to optimize prediction of future firearm violence so that prevention resources can be allocated efficiently. In service to that goal, we will recruit participants age 18-24 from three urban emergency departments, administer a comprehensive assessment, and use the measurements taken there to predict firearm violence over the following year. The proposed work will provide generalizable knowledge on what factors are most predictive of future firearm violence, which will contribute to future intervention strategies both in terms of content and in terms of optimally determining which people require intervention.